Understanding the individual and combined impact of childhood sexual abuse and minority stress on hazardous drinking among sexual minority women: Is emotion dysregulation a key factor?

PROJECT SUMMARY. Hazardous drinking (HD) is among the leading sexual orientation-related health
disparities impacting sexual minority women (SMW; e.g., lesbian, bisexual). Compared to heterosexual
women, SMW are approximately 7 times as likely to report alcohol dependence and over 8 times as likely to
report at least two negative social consequences (e.g., accidents, relationship problems) of alcohol use.
Although minority stress (e.g., internalized homophobia) has been identified as a leading risk factor for HD, it
does not fully explain sexual orientation-related disparities in HD. Adverse childhood experiences, such as
childhood sexual abuse (CSA), have also been identified as risk factors for HD among SMW. Specific
characteristics of CSA, indicative of severity (e.g., relationship to perpetrator, type of CSA), have been found to
increase risk for negative health outcomes, such as HD. However, although SMW more frequently report
having experienced CSA and more severe CSA experiences than heterosexual women, few studies have
examined how minority stress interacts with CSA (and its severity) to exacerbate risk of HD among SMW.
Research in the general population has demonstrated links between CSA and emotion dysregulation and
between emotion dysregulation and alcohol use—and there is an emerging literature showing associations
between minority stress and emotion dysregulation. Therefore, this study will examine the role of emotion
dysregulation, a transdiagnostic risk factor for psychopathology and substance use that impacts the ability to
manage emotional responses. To further clarify the pathway from emotion dysregulation to HD, the mediating
role of drinking expectancies (e.g., forgetting worries) in this relationship will also be examined. Study findings
have the potential to provide important information that can be used to develop more targeted prevention and
intervention strategies to reduce HD in SMW. Using data from a large and diverse sample of SMW in the
Chicago Health and Life Experiences of Women study (N~475), this study has two aims: 1) Examine the
independent and joint associations of CSA (and its severity) and sexual minority stress on HD; and 2) Examine
potential sequential mediation of emotion dysregulation and drinking expectancies in relationships between
CSA and HD, as well between minority stress and HD. In both aims, I will explore differences by sexual identity
and race/ethnicity and identify factors that account for potential disparities. The proposed research and training
are aligned with the National Institute on Alcohol Abuse and Alcoholism’s mission and the National Institutes of
Health Notice of Special Interest in Research on the Health of Sexual and Gender Minority Populations (NOT-
MD-19-001) and will help me to achieve the following training goals: 1) Increase knowledge of CSA among
SMW, including severity and SM people’s higher prevalence of CSA; 2) Develop expertise in the etiology and
epidemiology of SMW’s alcohol use and HD; 3) Strengthen statistical and methodological skills to conduct
complex quantitative analyses; and 4) Enhance skills in grant writing, research dissemination, and mentorship.

Public health relevance
PROJECT NARRATIVE Hazardous drinking is the leading sexual orientation-related health disparity impacting sexual minority women (SMW; e.g., lesbian, bisexual). While this disparity has primarily been attributed to exposure to minority stress (e.g., discrimination, stigma), minority stress, alone, cannot fully explain hazardous drinking disparities between SMW and heterosexual women. Therefore, this study will examine how other factors, including risk factors (e.g., childhood sexual abuse) and potential mechanisms (e.g., emotion dysregulation, drinking expectancies), combine with minority stress to increase SMW's risk for hazardous drinking.